Developing Research Careers in the Hearing Sciences II

Project Summary/Abstract
The specific goals for the proposed T35 Pre-Doctoral Research Traineeship Program at Vanderbilt University
Medical Center are to recruit high-quality students as T35 research trainees, provide a productive and
meaningful traineeship, nurture the foundation that transforms a clinical to research mindset, and facilitate
progression towards a career as an independently NIH-funded clinician-scientist. This program supports the
goal of the NIH to build a strong clinician-scientist workforce to meet biomedical, behavioral, and clinical
research needs. The proposed T35 traineeship program is specifically for graduate students in training for a
clinical doctorate in audiology (AuD). Scientists with a clinical background, such as audiology, are well
positioned to identify key clinically driven questions that will ultimately impact patient care and outcomes.
Despite the importance of engaging clinicians in research careers, the low number of individuals with clinical
training in audiology who are obtaining research expertise and credentials via a PhD in hearing science
remains a concern. Short-term support for three months of full-time research training is requested for five pre-
doctoral AuD students for each of the five years of the grant. Trainees will select from among eleven
preceptors in ten laboratories with active research programs in the Department of Hearing and Speech
Sciences at Vanderbilt University Medical Center. Each trainee will conduct hands-on research involving all
phases of a specific project in a laboratory under the guidance of their preceptor, complete formal training in
responsible conduct in research and research reproducibility, complete a T35 research course taught by the
T35 preceptors, participate in journal club discussions, and experience activities typical of a research career.
The Vanderbilt preceptors’ research areas span basic and translational research in animal and human models
and address a wide range of topics including cochlear and neural physiology, development, aging, hereditary
hearing loss, speech perception, multisensory cortical function, directional hearing and amplification, pediatric
audiology, cochlear implants and bimodal hearing, listening effort, and auditory fatigue. Trainees will learn
about the aspects of developing, designing, collecting, analyzing, and interpreting data, and reporting the
results of a research study. All trainees will present their research at a national scientific meeting and develop
a manuscript, in collaboration with their preceptor, publishable in a peer-reviewed journal. Strengths of the
proposed traineeship program include the standing of the Vanderbilt AuD program in the academic community,
the excellent research environment with state-of-the-art laboratories, numerous collaborations among the
preceptors, and strong institutional support. Independent researchers with clinical backgrounds are well suited
to identify and solve public health problems. The proposed program will provide research training with the goal
of developing a scientific mindset that leads the trainee to a research career. This will benefit society by
ensuring a strong future for evidence-based research related to hearing health and patient care.

Public health relevance
Project Narrative The proposed short-term research traineeship program provides a pathway for pre-doctoral students in the clinical field of audiology to expand their knowledge of research and foster development of a research mindset. Completion of this research traineeship will facilitate progression towards a career in research as a clinician scientist. Supporting an increase in the clinician-scientist workforce will benefit society by ensuring a strong future for discovery and advances in hearing health and patient care.